Improving the pharmacokinetics, potency, and immunogenicity of eCD4-Ig

PROJECT SUMMARY
We have developed an antibody-like HIV-1 entry inhibitor, eCD4-Ig, composed of the first two domains of
CD4 fused to an antibody Fc domain and a short tyrosine-sulfated CCR5-mimetic peptide. eCD4-Ig has
properties that make it an exceptionally promising tool in the fight against the HIV-1 pandemic.
Specifically, it is broader than any broadly neutralizing antibody (bNAb), at least as potent at
neutralization and antibody-dependent cell-mediated cytotoxicity (ADCC), more difficult to escape, less
immunogenic, and uniquely capable of amplifying the ADCC activity of non-neutralizing antibodies in
patient sera. When expressed by an adeno-associated virus (AAV) vector, it can protect rhesus
macaques from SHIV and SIV challenges more effectively than any conventional vaccine strategy, and,
as we show here, it can suppress viral rebound after cessation of combined antiretroviral therapies
(cART). In short, the case for optimizing eCD4-Ig is strong. Here we describe a series of cell-culture and
animal studies that will further extend eCD4-Ig’s half-life, improve its potency, and reduce its
immunogenicity. These improvements will increase the safety and efficacy of eCD4-Ig as an infused
protein and as an AAV-expressed transgene, and bring us closer to our goals of sustained drug-free HIV-
1 remission and effective long-term prophylaxis against HIV-1 infection.

Public health relevance
PROJECT NARRATIVE eCD4-Ig is an exceptional HIV-1 entry inhibitor that may help prevent new HIV-1 infections and maintain a drug-free state of HIV-1 remission in infected persons. Here we will extend its half-life, increase its neutralization potency, and reduce its immunogenicity, thereby improving its safety, efficacy, and cost.